CORE--RADIONUCLIDE PRODUCTION CORE

The Radionuclide Production Core consists of a JSW BC 3015 cyclotron for isotope production, remote systems for delivery of radionuclides to the chemistry production systems, instrumentation for quality control and transport and delivery systems for delivery of the final radiopharmaceuticals to the scanning suite. It is designed to respond to the radionuclide production needs of the clinical research projects and radionuclide needs of the radiochemistry research and developmental projects described in this grant. The clinical research projects, which include study of cognitive aspects of schizophrenia, Alzheimer's disease, Parkinson's disease and seizure disorders require the use of specific PET radiopharmaceutical agents. Those agents include 18FDG for glucose metabolic studies, and H215O for measurement of regional cerebral blood flow. The overall goal of the Radionuclide Production Core is thus achieved by meeting three specific aims: 1) production of radionuclides and labeled precursors required for patient, animal and chemistry/radiochemistry research and developmental studies; 2) maintenance, repair and support of the systems and facilities used for radionuclide production; 3) development of and/or adaptation of new or improved cyclotron, target, analytical and precursor systems to more adequately and efficiently meet the demands placed on the core. Major developmental activities, directly in support of the projects described in this grant include: provide H215O for bolus injection to facilitate activation studies, implement an appropriate 18F-fluoride method of 18FDG production to increase production capabilities, and provide backup target systems to minimize down-time.